RISK FACTORS FOR CVD IN WOMEN

Abstract
Circulating proteomic profiles are strongly influenced by diet and may act as important molecular
transducers of the diet’s effects on coronary heart disease (CHD). Dietary quality and
circadian/temporal eating habits have been consistently related to CHD. However, how these factors
may affect CHD progression mechanistically remains poorly defined. Recent studies indicate that diet is
among the leading factors determining personalized and diet-specific differences in the proteome and
proteotypes defined by specific combinations of proteomic profiles. The overarching goal of this
proposal is to perform proteome-wide study of the dynamic interrelationships between diet (quality and
circadian/temporal eating patterns), circulating proteomic profiles, and CHD risk. Using an exceptionally
cost-efficient design that leverages existing resources from six large prospective cohorts: the Nurses’
Health Study (NHS), NHS2, the POUNDS LOST trial, Jackson Heart Study (JHS), Coronary Artery Risk
Development in Young Adults (CARDIA) Study, and UK Biobank, we propose to identify the
proteotypes for the dietary quality and circadian/temporal eating patterns measured by ‘gold standard’
and objective nutrition assessment methods (Aim 1). We will examine the associations of circulating
proteomic profiles (dietary factors and circadian/temporal eating patterns-related proteotypes, and
proteome-wide profiles) and their dynamic changes over 10 years with incidence of CHD (Aim 2). We
will also assess whether non-protein vascular risk factors for CHD mediate the proteome-CHD relation
(Aim 3). In addition, we will perform multi-omics analysis on the proteome-metabolome associations
with CHD (Aim 4). This renewal application is built upon an exceptional resource for understanding
CHD risk factors in women and has been continuously funded for 38 years (resulting in >410
publications and contributing to the training of >200 early-career investigators). The findings of our
proposed project are expected to lead to identification of new determinants of CHD at the molecular
level, offer novel insight into the mechanistic pathways, and advance the development of new
preventive and therapeutic strategies.

Public health relevance
Narrative Circulating proteomic profiles are strongly influenced by diet and may act as important molecular transducers of the diet’s effects on coronary heart disease (CHD). Using exceptional resource from six independent and well-characterized prospective cohorts, the study proposes to perform proteome-wide study on the dynamic interrelations between diet (quality and circadian/temporal eating patterns), circulating proteome and its changes over 10 years, and CHD risk. We will also investigate the mediation effects of non-protein vascular risk factors, and multi-omics proteome-metabolome associations with CHD. Our findings are expected to provide novel insight into the mechanistic pathways, and advance the development of new preventive and therapeutic strategies.